CE24-012 - The Impact of Recreational Cannabis Legalization on Substance Use Outcomes

PROJECT ABSTRACT
This project will rigorously assess the impact of recreational cannabis legalization on opioid use and overdoses
across the United States. With nearly half of the U.S. population living in states where recreational cannabis is
legal, and ongoing policy shifts influencing its availability, this research is both timely and critical. The study will
have two specific aims: first, to measure the effects of recreational cannabis legalization on substance use for
self-management of pain, utilizing a nationally representative survey with detailed drug-use data; second, the
project will quantify the impact of these policies on opioid morbidity and mortality, combining survey data with
nationwide overdose data to assess changes in non-fatal and fatal overdoses. For each aim, the team will test
for differences in the impact of cannabis legalization across 1) policy implementation characteristics and 2)
individual sociodemographic determinants of health. The research approach will employ a rigorous, quasi-
experimental statistical methodology, led by a multidisciplinary team of experts in substance use policy
research, addiction medicine, and statistical methods. The outcome of this study will provide crucial evidence-
based information to inform policymakers and public health officials in crafting effective interventions that
address the complex relationship between cannabis policy, health disparities, and substance use outcomes.

Public health relevance
PROJECT NARRATIVE This research project will contribute to public health by providing essential data on the effects of recreational cannabis legalization on substance use and overdose rates. In an era where cannabis policies are rapidly evolving, understanding these impacts is critical for developing informed public health strategies. The findings will guide policymakers in creating interventions that improve health outcomes, lengthen life, and reduce illness and disability, especially among individuals most affected by these policies.